Administrative Core

ABSTRACT
The Administrative Core will provide managerial support for an enterprise capable of conducting syphilis
research on the scale required to produce a vaccine with global efficacy. Such an enterprise requires 1) a broad
base of epidemiologic, public health, clinical, translational, and basic research expertise among its
investigators; 2) a combination of world-class research infrastructures; 3) clinical sites representing diverse
STI populations, each with experienced, committed administrative/support personnel, deep local ties to
patient populations, on-site capacity to process specimens, and experience securely transmitting specimens
and data to collaborating institutions; and 4) a wealth of administrative experience to connect clinical sites
with research institutions in the United States. The proposed Administrative Core builds upon collaborative
research and administrative networks that are already well-established. All three principal participating
institutions have deep academic and administrative ties to one or more of the foreign institutions or
international consortia that directly administer or serve as partners in the management of our clinical sites.
These institutions also provide the leadership and scientific and administrative skills that make the project
possible. Both project leaders are internationally recognized research scientists with extensive experience with
international collaboration and interdisciplinary research. The Project Directors bring deep knowledge of a rich
variety of scientific fields. A team of seasoned administrators from the principal institutions will pool diverse
backgrounds, providing needed administrative skills and experience. Building on this foundation, the proposed
Administrative Core will implement five core managerial functions as its Specific Aims: (i) Management and
Oversight. The Steering Committee will outline milestones and timelines and track progress. The Core
managerial team will provide Project and Core Leaders with all needed administrative assistance, coordinate
and promote communication within the CRC, provide financial management, and ensure compliance with all
university and government regulations. (ii) Data Management. The Core data management team will establish
a central REDCap Syphilis Database that will allow seamless, secure, HIPAA-compliant sharing of human-
related data. (iii) Statistical Support. Experienced biostatisticians will provide statistical support for
experimental design and data analysis. (iv) Training, career development, and mentorship. The CRC's
Development and Research Program will foster scientific creativity, laboratory competence, and intellectual
independence, and create mentorship opportunities. (v) Syphilis community outreach. Drawing on their
extensive experience with local community organizations, each site will conduct syphilis community outreach
activities that will enhance patient enrollment and establish strong community relationships, laying the
foundation for a subsequent multi-site syphilis vaccine trial.